Administrative Core

Modified Project Summary/Abstract Section – for Administrative Core (P20 GM130423-06).
TThe long-term goal of the Kansas Institute for Precision Medicine (KIPM) is to develop a multi-disciplinary research program focused on precision medicine to advance healthcare through innovative discoveries. This Phase 2 COBRE program will provide unique training for biomedical researchers focused on the theme of precision medicine by providing the appropriate financial support, dedicated mentoring teams, and a strong research infrastructure, which includes an active patient and community engagement program. The responsibilities of the Administrative Core will include actively monitoring an extensive mentoring program for Research Project Leaders (RPLs), overseeing a robust research Pilot Projects Program (PPP), arranging for reviews by a newly formed Advisory Committee (AC), composed of nationally-recognized experts in the biomedical sciences. The Administrative Core will also oversee the COBRE Research Cores, i.e., the Biomedical Engineering (BME), Biobanking and Biomarker Validation (BBV), and Quantitative ‘OmiCs’ (QOC) Cores. The KIPM Phase 2 COBRE will continue to be led by Andrew K. Godwin, PhD (Director), Steven A. Soper, PhD (Associate Director), and Alan S.L. Yu, MB, B. Chir (Director of Mentoring and Career Development) and will position promising young scientists to effectively compete for independent research funding. The Administrative Core will play an important role in the COBRE program by setting the overall scientific direction of KIPM’s activities, coordinating all KIPM’s functions, establishing areas of research emphasis, and promoting internal and external collaborative interactions. This Core will be responsible for the overall management of the administrative, fiscal, and scientific aspects of KIPM. Dr. Godwin will have primary administrative oversight of the COBRE through the Administrative Core, but all KIPM activities will be managed and evaluated jointly by the three principal investigators, who are seasoned leaders of large NIH projects. The specific aims of the Administrative Core are to: 1) Establish the overall scientific direction of the KIPM COBRE; 2) implement a scientific and career development plan for RPLs; 3) administer and evaluate a research PPP for Pilot Project Leaders; 4) convene AC meetings to review the KIPM (goals and progress); and 5) enhance knowledge of KIPM faculty through training, mentorship and patient engagement to better address the needs of the patients who their research will impact. These activities will be assisted by Ms. Jessica Leib (KIPM COBRE administrator), who will be responsible for day-to-day administrative oversight of the COBRE and Ms. Allison Moore (Executive Assistant to Dr. Godwin), who will help oversee the finances of the entire program. Both will work to gather and organize information quarterly related to the Research Performance Progress Reports, including the progress of RPLs and their metrics. Overall, the proposed KIPM COBRE Administrative Core will promote and strengthen interactions between the COBRE and the parent institution by interfacing its activities with other programs, centers, and institutes at KUMC, and by integrating the biomedical research cores with existing institutional shared resource centers to expand their impact.